Toward an animal model of visual simulation

Abstract/Summary
The goal of this project is to develop an animal model for visual simulation. In particular, we aim to show
that animals, like humans, can engage in extended visualization of events not present in the external world.
This capacity is essential, as it allow animals to test strategies and reason about the world using internal
visual machinery. Until now, almost all exploration of visual simulation has been carried out in humans, as
verbal instructions are the most common way to evoke controlled imagined experiences. Here we introduce
a novel task, initially tested in humans, to non-human primate subjects. In Aim 1, we will show that their
performance in this task mirrors that of human subjects. We will then have these trained animal subjects
participate in awake fMRI studies while performing this task, and associated controls, in order to test the
hypothesis that the same visual circuits involved in active perception of dynamic visual events are recruited
during internally driven visual simulation of these events (Aim 2). Successful completion of these aims will
provide a key starting point for the first systematic neurophysiological investigations of visual mental
simulation at the single neuron level. This has significant implications for understanding the rich interplay
between the visual system and higher mental function in both normal perception and neurological disease.

Public health relevance
Project Narrative The goal of this project is to establish an animal model for visual imagery and mental simulation that can be used to further our understanding of how internally generated sensory experiences arise in the brain. Imagination and mental simulation are crucial for a variety of daily functions, including planning, perception, and social cognition. We seek to develop an animal model for visual imagery, as previous work has focused almost exclusively on humans, laying the groundwork for gaining a more sophisticated understanding of its underlying neural mechanisms which is essential for the treatment of individuals suffering from disorders linked to deficits in visual processing and mental imagery such as visual hallucinations, schizophrenia, and PTSD.